Elucidating the role of nonessential amino acid metabolism in diabetic skin wounds

PROJECT SUMMARY
Type II diabetes takes a large toll on both individuals and society through morbidity and financial burden.
Patients with diabetes are at risk of developing diabetic foot ulcers that are nonhealing and can lead to
infections and amputations. The pathophysiology that underlies this impaired wound healing can be due to
damage to blood vessels, neurons, and immune function, all of which contribute to delayed wound healing.
Normally, skin requires nutrients like nonessential amino acids for building material and energy to undergo
repair and heal wounds. My preliminary metabolomics data in different wound regions in control and db/db
mice indicate that four nonessential amino acids, including serine and glycine, are particularly depleted in
diabetic wounds, suggesting their important biological roles in wound healing. Previous studies of diabetic mice
and humans have also found a reduction of serine and glycine within wounds and systemic blood. However, it
remains unknown why they are depleted, whether they are required for wound healing, and how they are used
for healing. Thus, identification of the cause of their reduction and usage by different cell populations during
wound healing in diabetic models will facilitate the future development of new therapeutics. To this end, I will 1)
define the distribution and fates of the four nonessential amino acids in different wound regions in healthy and
diabetic mice; and 2) determine whether serine and glycine supplementation can promote wound healing. My
proposed study will utilize a broad spectrum of innovative tools including in vivo stable isotope tracing coupled
with high-resolution mass spectrometry-based metabolomics, microscopy, and cell sorting. This study will
expand our understanding of how efficient nutrient utilization facilitates wound healing in normal and diabetic
wounds. The findings from this study will also generate important implications regarding potential targets for
future pharmacological or genetic knockout experiments in the effort toward developing novel therapies for
improving diabetic wound healing.

Public health relevance
PROJECT NARRATIVE Diabetes can lead to complications like diabetic foot ulcers, which are nonhealing and may lead to morbidity and death. How small metabolites are utilized in normal wounds and altered in diabetic wounds remains understudied. By investigating metabolite utilization spatiotemporally and by host cells, this study aims to understand how alterations in metabolic usage contribute to delayed wound healing in diabetes.